High-throughput immunoproteomics for cancer biomarker discovery

Abstract
The goals of the Administrative Core are to provide the organizational, financial, communication, networking and
resource infrastructure required for the success of the Biomarker Discovery Lab and the Biomarker Reference
Lab. Although the research activities in each project are of paramount importance, the Administrative Core will
serve as the hub through which the Center is organized. The Administration Core will facilitate leadership,
direction of the research, financial management, and administrative activities to coordinate the clinical and basic
science activities of the ASU Biomarker Characterization Center (ASU-BCC) for each project efficiently.
Importantly, the Administrative Core will schedule full and focused team meetings. It will facilitate resource
sharing among the ASU BCC projects as well coordinate collaboration with other EDRN sites with the ultimate
goal of sharing research findings and advances. The Administrative Core will set the overall organizational
structure of the Center, direct communication within the Center and between the Center and the EDRN Steering
Committee, with NCI partners, as well as communication of the results of the Center to the greater community.